Recombinant human CC10 protein for treatment and prevention of chronic lung allograft dysfunction

Abstract
Over 5,000 lung transplants (LTx) are performed in the US each year to save the lives of patients
in respiratory failure due to COPD, idiopathic pulmonary fibrosis, cystic fibrosis, pulmonary
hypertension, and other terminal lung conditions. The vast majority of LTx, long-term survival is
significantly limited by chronic lung allograft dysfunction (CLAD) with a median survival of 6 years
post-transplant. New therapies are urgently needed to improve clinical outcomes in LTx and
CLAD. Native CC10/SCGB1A1 is an important host defense, immunomodulatory, and
homeostatic protein in the lungs, which is known to be deficient in CLAD. Recombinant human
CC10 protein (rhCC10) can augment native CC10 levels in vivo and is a biologic candidate
potentially to treat and prevent CLAD. It has shown efficacy in decreasing lung histopathology in
a murine models of; 1) orthotopic lung transplant model of CLAD, 2) bronchiolitis obliterans
caused by orthotopic bone marrow transplant, in addition to reducing pulmonary inflammation and
fibrosis in several other animal models of acute lung injury and pulmonary fibrosis. RhCC10 was
also shown to be safe in 3 human studies and showed potent anti-inflammatory effects in the
lungs of severely premature infants experiencing respiratory distress. In CLAD patients, the
optimal route of administration is by inhalation, however, inhalation is an inherently inefficient
delivery method. Up to 70% of each drug dose may be wasted, therefore, it is advantageous to
optimize drug potency to enable production and delivery of sufficient quantities to impact clinical
endpoints. Our group has developed methods to enhance the potency of rhCC10 and the
proposed studies will scale-up these methods, characterize the resulting products, and optimize
them for maximal anti-inflammatory activity to lay groundwork for in vivo studies of preparations
with enhanced potency.

Public health relevance
The proposed research will contribute to our fundamental understanding of the impact of reactive oxygen species on CC10 activity, as well as of the processes underlying the development of CLAD/bronchiolitis obliterans and immune-mediated airway injury. It could also lead to not only development of novel biologic therapeutics to prevent and/or treat CLAD with improved clinical management of CLAD patients but also may reveal new therapeutic approaches that could enhance the health and lifespan of lung and other transplant recipients.